Rewired Metabolism and Immunosuppression in MYCN-driven Neuroblastoma

PROJECT SUMMARY
Amplification of the oncogene MYCN drives high-risk progressive disease, resistance to therapy, and a poor
overall survival rate below 45% for high-risk neuroblastoma (NB) patients. Further, more than half of all high-risk
patients will relapse, and the post-relapse survival rate is only 10%. MYCN-driven NB tumors have poor immune
responses due to a relatively low mutational load, low MHC-I expression, and reduced immune cell infiltration.
As a result, NB is often immunologically quiescent, thus limiting immunotherapy approaches. MYCN amplification
has a central role in orchestrating the metabolic reprogramming that favors NB growth and adaptation to its
microenvironment. Tumor cells and immune cells exist in a complex environment where they share and compete
for specific nutrients. Through unbiased transcriptomics, metabolomics, and immune profiling of TH-MYCN GEM
and syngeneic mouse models of NB, we have identified cysteine metabolism as a selective vulnerability in
MYCN-driven NB. We have also found that MYCN drives an immune suppressive tumor microenvironment
(TME) during oncogenesis, and reprograms NB tumors to create a cysteine-poor TME. By lacking de novo
biosynthetic enzymes, T cells are exquisitely vulnerable to cysteine starvation, while cysteine supplementation
restores T-cell activation, expansion, and effector functions. Our central hypothesis is that MYCN-driven tumor
intrinsic metabolism and recruitment of other cysteine-consuming cells (such as PMN-MDSCs) deplete
extracellular cysteine, thus blocking T cell anti-tumor activity. This proposal aims to: (1) elucidate how oncogenic
MYCN rewires the metabolic environment of NB to drive immune suppression; and (2) modulate the metabolic
environment of NB to enhance immune-based approaches for high-risk MYCN-amplified disease.

Public health relevance
PROJECT NARRATIVE Strategies disrupting MYCN oncogenic programs are critically needed for neuroblastoma therapy. High-risk, MYCN-amplified neuroblastoma is characterized by high relapse and mortality rates, dysregulated tumor metabolism, and an immune-suppressive tumor microenvironment. As the development of effective immunotherapies requires new definitions of the negative regulations impairing an adequate immune response, our proposed research will provide a novel view on how oncogenic MYCN reprograms the metabolic environment of NB to drive immune evasion. Our proposed research will also aim at modulating the metabolic environment of neuroblastoma to enhance immune-based approaches for high-risk MYCN-amplified disease.